Repurposing Space for the Behavioral Neuroscience Laboratory and Vivarium Facility at Roger Williams University

RI-INBRE Alteration & Renovation Project Summary
The overarching goal of the Rhode Island IDeA-Network of Biomedical Research Excellence (RI-INBRE)
program is to improve institutional capacity for biomedical research excellence and student experiential training
in the State of Rhode Island. RI-INBRE infrastructure investments are one key tool in enhancing biomedical
capacity at network institutions. One mechanism for this investment is the availability of INBRE Alteration and
Renovation (Alt & Reno) funding. Roger Williams University (RWU) is one of six RI-INBRE network primarily
undergraduate institutions and is in the early stages of expanding its biomedical research capacity. In this
renewal application, we propose using Alt & Reno funds to construct a rodent housing facility (i.e., vivarium) at
RWU. This facility represents an important investment in RWUs commitment to research and engaged learning,
and it is designed for use by both investigators and research courses. RWU has identified an available ground
floor area with the appropriate square footage, low ambient noise level, and infrastructure to support the
renovation. Importantly, RWU has made a significant institutional commitment to this effort and will contribute
57% of the cost of the renovation. This project will allow investigators to conduct rodent experiments in-house
instead of traveling to Brown University. In addition, the new vivarium will be critical to RWU’s ability to attract
new investigators with robust biomedical research programs. This Alt & Reno project represents a critical
capacity-building step for RWU and will significantly enhance the biomedical research infrastructure at a PUI in
Rhode Island.